Contribution of germline copy number variations to the susceptibility of aggressive prostate cancer in men of African and European ancestry

PROJECT ABSTRACT
Inherited genetic variation is a key component in the etiology of prostate cancer (PCa). More than 450
common single nucleotide variants (SNVs) for PCa have been identified in large-scale multi-ancestry
genome-wide association studies (GWAS) and rare pathogenic SNVs in >30 PCa candidate genes have
been implicated across ancestry populations. Although somatic copy number alterations are commonly
observed in prostate tumors and predict poor outcomes, studies are limited in evaluating the contribution of
germline copy number variations (CNVs) to PCa risk, due to the technical challenges of detecting germline
CNVs from genotype and sequencing data. CNVs, the deletion and duplication of DNA segments ≥50 bp,
are a prominent class of genetic variation that has critical impacts on human health and disease. Studies
with array intensity data have found evidence of both common (≥1%) and rare (<1%) CNVs associated with
risk of total and/or aggressive PCa, but these analyses were limited to only large CNVs (>1kb), mostly
conducted in populations of European ancestry, and had no or limited focus on aggressive disease. For a
thorough investigation of germline CNVs on PCa risk, we propose to combine imputation and sequencing-
based approaches to maximize the ascertainment of CNVs across the frequency and size spectrum in the
human genome. Leveraging existing GWAS, whole-exome sequencing (WES) and whole-genome
sequencing (WGS) data from large-scale studies with disease aggressiveness well-defined, we are well-
powered to examine the association of CNVs with risk of total and aggressive PCa and evaluate the joint
contribution of CNVs and SNVs on PCa risk. In Aim 1, we will use the 1000 Genomes Project (1KGP) 30X
reference panel to impute common CNVs and test their associations in >24,000 men of African ancestry
and >113,000 men of European ancestry with GWAS array data. In Aim 2, we will apply GATK-gCNV to
detect rare coding CNVs of all sizes in >12,000 men of African ancestry and >41,000 men of European
ancestry with WES data. The aggregate association of rare CNVs will be evaluated in gene-based and gene-
set analyses. In Aim 3, CNVs of all sizes and frequencies across the genome will be detected using DRAGEN
in >10,000 men of African ancestry and >182,000 men of European ancestry with WGS data. Analyses in
WGS studies allow for a comprehensive assessment of CNVs genome-wide, independent replication of risk-
associated CNVs identified from GWAS or WES studies, and an integrated analysis of polygenic risk score
(PRS) and rare CNVs and rare pathogenic SNVs in candidate genes to understand their joint effects on PCa
risk and disease aggressiveness across populations. We expect this study to provide the most
comprehensive and well-powered investigation of germline CNVs in PCa across populations to date. This
study has the potential to advance the field through discoveries of novel risk variants for PCa that could
elucidate underlying biological mechanisms and improve risk stratification across diverse populations.

Public health relevance
PROJECT NARRATIVE The primary goal of this study is to identify germline copy number variants (CNVs) associated with risk of total and aggressive prostate cancer in men of African and European ancestry. Findings from this study will provide valuable insights into the role of CNVs in susceptibility of prostate cancer, which has not been the focus of past genetic studies. The identification of risk-associated CNVs will also improve our understanding of the genetic architecture of prostate cancer and aid the development of more comprehensive risk prediction models of prostate cancer across populations.